DEVELOPMENT OF GENETIC PROFILES FOR INBRED LABORATORY RODENTS

This project is designed to identify and locate on the chromosomes of inbred rodents inherited characteristics which can be used in a wide range of biomedical research and to further the ability of the Genetic Monitoring Unit to perform its basic mission. The major areas of interest are: 1) characterization of the genetic traits by biochemical and immunological techniques; 2) chromosome mapping by standard genetic analysis; and 3) application of the genetic characteristics to explore new animal models of pathogenesis.